Cancer Genome Dynamics (CGD) Research Program

PROJECT SUMMARY/ABSTRACT
The Cancer Genome Dynamics Program (CGD) investigates how DNA sequence, DNA methylation, chromatin
modifications, DNA damage, and 3D chromosomal organization coordinately affect transcriptional output. CGD
laboratory scientists gain insight into how alterations at any of these levels initiate and/or promote tumor
formation and progression, and CGD clinical investigators translate these discoveries into new prevention
strategies, diagnostic technologies, and cutting-edge clinical trials. The Program focuses on major cancer
burdens and disparities in our catchment area, guided by formal interactions via the CGD designated Liaison
with the Community Outreach and Engagement Core, Program meetings and retreats, and close engagement
with PCC Disease Management Groups and Disease Centers. Emphasis is placed on breast cancer, prostate
cancer, and multiple myeloma in the Black and Ashkenazi populations of our catchment area. CGD is also home
to faculty who investigate the carcinogenic impact of the World Trade Center (WTC) disaster, smoking, air
pollution, metals, and other toxic agents. Research in CGD is focused around three thematic aims: Aim 1: To
determine fundamental mechanisms of genetic and epigenetic regulation and their dysregulation in cancer, Aim
2: To elucidate the role of DNA damage and repair in tumorigenesis and cancer progression, and Aim 3: To
discover changes in chromosome architecture that activate oncogenic transcriptional programs. CGD has 3 co-
leaders, Hannah Klein, PhD (Basic), William Carroll, MD (translational) and Faith Davies, MD (clinical). Our
58 Members and 8 Associate Members come from 9 Departments at NYU Grossman School of Medicine, and
two other NYU campuses. Current cancer-relevant funding is $27.3M, with 7.7M from the NCI, a 91% increase
since 2018, which has led to an increase in the depth and breadth of the Program. Members published 1,094
cancer-related papers (a 52% increase from the last funding cycle), including 21% intra-programmatic, 29%
inter-programmatic, and 45% inter-institutional (with other NCI-CCs) collaborative manuscripts. Our basic
research resulted in numerous high-impact, paradigm-shifting publications (35% in journals with IF >10; 17% in
those with IF>15), new intellectual property, new drug discovery companies, and innovative clinical trials. CGD
clinical investigators accrued 2,523 patients to interventional and non-interventional clinical trials during the
funding period. Members extensively use and have enhanced PCC Shared Resources with new computational
pipelines, humanized mouse models that incorporate custom designed synthetic DNA molecules, ‘on demand’
PDX lines, and single molecule biophotonics. We also develop cutting-edge molecular genetic tests for clinical
use.